Deep mutational scanning of CHD2 for variant interpretation in neurodevelopmental disorders

Project summary
De novo pathogenic variants in CHD2 are one of the most common causes of the neurodevelopmental
disorders (NDDs) that include refractory epilepsy, intellectual disability and autism spectrum disorders. In
addition, somatic CHD2 variants, acquired later in life, are highly recurrent in certain types of leukemias. For
both types of conditions, loss-of-CHD2 function is the likely pathogenic mechanism, and most variants are
truncations. However, there is also evidence that missense variants can disrupt or abrogate CHD2 function,
leading to loss-of-function, though they are harder to interpret, and many are classified as variants of uncertain
significance (VUS). VUS are one of the biggest challenges for human geneticists, and represent the biggest
class of variants returned on clinical genetic test reports, in part because we have a poor understanding of how
missense variants impact protein function. Our research addresses these challenges by designing a bimodal
high-throughput assay to determine the impact of VUS on CHD2 function using downstream protein
abundance (Aim 1) and the CHD2 episignature (Aim 2). We will leverage the fact that CHD2 is a chromatin
remodeler and thus affects both downstream protein expression and the DNA methylation landscape to
develop a high-throughput, multimodal approach to identify variants that alter CHD2 function. We will also
implement prime-editing using pools of pegRNAs to create 30 CHD2 variants and multiplex this assays, with a
view to scale to hundreds of CHD2 variants in future work. Our work and approach has broad appeal as it can
be scaled to include other NDDs and cancers in the future. Finally, the goal of this research is to develop an
experimental paradigm that can be scaled to resolve all CHD2 VUS, providing answers for patients and
families, and identifying those individuals that will be eligible for precision therapies in the future.

Public health relevance
Proposal narrative Pathogenic variants in CHD2 have been implicated in neurodevelopmental disorders and cancer and the pathogenic mechanism is likely haploinsufficiency. Missense variants likely also cause haploinsufficiency by abrogating protein function, but are more difficult to interpret, and many are variants of uncertain significance (VUS). Here we will design multimodal high-throughput assays for multiplexed gene-editing of CHD2 for resolution of VUS.